Interferon-inducible cell-intrinsic host defense against Chlamydia trachomatis

Chlamydia trachomatis is the cause for the most common bacterial sexually transmitted infection in the
United States. Commonly referred to as a silent epidemic, C. trachomatis infections in women are frequently
asymptomatic, and often go unnoticed and untreated. The infection can persist for months or years and
ultimately cause pelvic inflammatory disease, ectopic pregnancies, and infertility. In order to establish
persistent infections, C. trachomatis must subvert both the innate and the adaptive branches of the immune
system. A central node that connects adaptive and innate immunity to C. trachomatis is the cytokine
gamma-interferon (IFNγ). This cytokine is produced by lymphocytes such as T cells of the adaptive immune
system and induces cell-intrinsic, innate host defenses against Chlamydia in epithelial cells. In order to
overcome IFNγ-mediated immunity and replicate inside human epithelial cells, C. trachomatis evolved
counterdefenses specifically adapted to its human host. These C. trachomatis counterdefenses and the
corresponding repertoire of IFNγ-inducible anti-Chlamydia defense programs are poorly characterized. Our
goal is to decipher this interplay between IFNγ-mediated host defense and chlamydial counterdefense, as
such knowledge holds the potential to instruct the design of improved treatment options. To achieve this
goal under Aim1, we designed unbiased functional genomics screens to identify human IFNγ-inducible
genes (ISGs) that exert potent anti-Chlamydia defenses. In parallel we employ defined C. trachomatis
mutant libraries in functional bacterial genetic screens to identify C. trachomatis genes that subvert ISG-
driven defense pathways. As proof-of-principle we already identified i) human ISGs with not-previously-
described anti-Chlamydia activities and ii) C. trachomatis mutants that are hyper-susceptible to IFNγ-
activated host defenses in human cells. These novel human defense pathways and the corresponding
C. trachomatis evasion mechanisms will be characterized through multidisciplinary approaches in Aim1. As
an interrelated second aim, we will dissect the role of IFNγ in C. trachomatis-induced inflammation, which
underlies Chlamydia-associated diseases. Although best known as a potent inducer of cell-intrinsic
immunity, IFNγ also functions as a critical regulator of inflammation and associated diseases. We
discovered that specific members of the superfamily of IFNγ-inducible dynamin-like GTPases control
Chlamydia-induced activation of inflammasomes, a class of cytosolic immune sensors that drive
inflammation. Using organoid and other mouse and human cell culture systems as well as novel in vivo
mouse models, we will in Aim2 define the function of IFNγ-inducible GTPases in Chlamydia-triggered
inflammation and in vivo pathogenesis. These studies will reveal critical insights into the role of IFNγ in the
immunopathology of Chlamydia infections with the potential to guide the development of new therapeutic or
prophylactic treatments or vaccine designs.

Public health relevance
Chlamydia is amongst the most common causes of sexually transmitted infections and can lead to pelvic inflammatory disease, life-threatening ectopic pregnancies and infertility in women. Disease is linked to the ability of Chlamydia to establish persistent infections in spite of an inflammatory host response. This research will define how Chlamydia induces inflammation but avoids clearance by human immune programs, and it will thereby pave the way towards the development of novel treatment options and improved vaccine strategies.